Wireless implantable cardiac systems for continuous multiparametric investigation of cardiac arrhythmias in vivo

Project Summary
Arrhythmias are life-threatening heart rhythm disorders that significantly impact the quality of life for millions
of patients in the United States. They are associated with abnormalities in myocardial electrophysiological
properties and calcium handling. Specifically, heart contraction and relaxation are regulated by intracellular
calcium, which rises and falls in response to membrane potential depolarization and repolarization. In turn,
calcium influences membrane potential via calcium-dependent ionic currents. One major challenge in studying
arrhythmia mechanisms is the lack of techniques to simultaneously map and modulate calcium transients,
electrical activities, and excitation-contraction coupling over time from the beating heart in vivo. The R01 proposal
aims to overcome these limitations by developing a wireless, soft, implantable platform for in vivo cardiac
calcium-voltage mapping and pacing. The device will be used to gain new mechanistic insights into arrhythmia
pathogenesis and treatment. It comprises a soft probe, a wireless electronics module, and graphical user
interfaces. The probe integrates arrays of sensors and actuators to enable colocalized, crosstalk-free
spatiotemporal mapping of electrical excitation and calcium signaling, with additional options for cardiac pacing.
Its mechanically soft design allows it to conform to the highly curvilinear epicardial surfaces and withstand
repetitive strains from the heartbeat. The miniaturized wireless electronics module will be optimized for energy
harvesting, storage, control, and bidirectional data communication, designed for full subcutaneous implantation
and long-term in vivo studies with minimal impact on small animals. The user interfaces will enable real-time
control of device operation and data analysis. The proposed work will be fulfilled via three Aims: In Aim 1, we
will develop the soft cardiac calcium-voltage mapping and pacing probe; In Aim 2, we will design and optimize
fully implantable Bluetooth based wireless electronics and software interfaces to support chronic in vivo
operations of the probe; In Aim 3, we will use the system to systematically study electrical excitation, calcium
signaling, and their interactions during arrhythmia development, progression, and pacing treatment with three
common clinically relevant arrhythmias: ventricular tachycardia, atrioventricular block, and atrial fibrillation.
The proposed work builds on our recent development of a flexible, wireless optoelectronic interface for acute
and regional calcium-voltage mapping of heart function in vivo. Successful completion of this project will produce
a first-of-its-kind in vivo platform to comprehensively study calcium, voltage, and their coupling in heart function
and diseases. This technology holds the potential to greatly enhance our ability to investigate and treat cardiac
conditions, with implications for widespread clinical applications. To maximize the impact, the team will make all
tools and methods as freely as possible, host visitors for hands-on learning, and pursue commercialization
opportunities to enhance scalability, tunability, and robustness for broader adoption.

Public health relevance
Project Narrative A deeper understanding of arrhythmia mechanisms and therapeutic strategies requires techniques that can simultaneously map the spatiotemporal electrical excitation and calcium handling from and deliver electrotherapy to the beating heart in vivo. Our multidisciplinary team will develop a wireless, soft, calcium-voltage mapping and pacing implant, and apply it to chronically study calcium dynamics, electrical excitation, and their combined effects on excitation-contraction coupling during clinically relevant arrhythmias and electrotherapy in freely behaving animals. This work will transform cardiac research by providing innovative techniques for investigating arrhythmias in behaving subjects and potentially revolutionizing clinical approaches to diagnosing and treating various heart diseases.